General and High-Throughput Small Molecule Screens and Selections for Metabolic Engineering

Project Summary
The objective of the parent award is to create general, high-throughput assays that are modular and broad in
scope to overcome the current bottleneck in testing the enormous diversity required for solving metabolic
engineering problems. If successful, these technologies will enable powerful directed evolution approaches to
be routinely applied to the biosynthesis of natural products and their analogs. Metabolic engineering involves
library sizes of up to 1020, many orders of magnitude beyond now routine protein engineering, because multiple
genes not only in the biosynthetic pathway but also in the host strain background must be optimized often
synergistically. Yet, today metabolic engineering is primarily performed by introducing just a few genetic
modifications at a time and then assaying the resulting strains by low throughput gas- and liquid-chromatography
mass spectrometry (GCMS and LCMS) methods. We intend to only use LCMS to confirm our assay results,
significantly reducing cost and time associated with these methods. Previous high-throughput assays employed
in metabolic engineering have been limited to unusual molecules, such as chromophores. Thus, here we apply
the concept of displacement of a competitor molecule from a protein receptor to develop two general assays for
metabolic engineering: the fluorescence polarization (FP) assay and the yeast three-hybrid (Y3H) selection. The
FP assay would be implemented as a first-generation, medium throughput screen, as a step stone to the Y3H
which would have higher throughput of greater than 108. When carried out under the conditions of sexual
reproduction with mutagenesis via homologous recombination (HR), libraries of greater than 1020 can be
searched. In collaboration with the Tang laboratory (UCLA) and the Snyder laboratory (UChicago), we challenge
our technology with the metabolic engineering mission of increasing production titers of the fungal
anhydrotetracycline TAN-1612 and generating biologically active analogs in S. cerevisiae for combating antibiotic
resistance and applications beyond.